Discovering and Exploiting Selectivity within Tandem Bromodomains

PROJECT SUMMARY
Members of the bromodomain and extra-terminal domain (BET) family (Brd2, Brd3, Brd4, Brdt) each contain
two bromodomains that bind acetyl-lysines on histones and transcription factors. The importance of BET-
regulated transcription in human disease is well appreciated with pan-BET bromodomain inhibitors in phase I/II
clinical trials for multiple cancers and phase III trials for type 2 diabetes subjects with coronary artery disease.
Despite these achievements, several critical questions remain. For example, BET proteins are localized
disproportionately at super-enhancers, genomic regions with large clusters of elements that enhance gene
transcription. The basis of this localization is unknown but important given that super-enhancers are enriched
at loci with oncogenic potential. Our unpublished data support the hypothesis that tandem bromodomains act
as a scaffold for acetylation-dependent reorganization of chromatin; for instance, joining promotors with their
corresponding distal enhancers to drive transcription (Focus 1). However, the ability of tandem bromodomains
to scaffold nucleosomes and transcription factors in an acetylation-dependent manner has not been shown.
We take an innovative structural and biophysical approach to investigate the role of Brd4 in maintaining
chromatin conformations that facilitate enhancer-driven oncogenic gene transcription. This mechanism of
chromatin reorganization, if true, is paradigm shifting and would have broad impact on studies of tandem
histone-binding domains. We also hypothesize that metabolic changes induce distinct post-translational
modifications on histones that are “read” by bromodomains. Yet, the broader acylation and protein binding
specificity of bromodomains is poorly understood. We have begun to address this knowledge gap in our recent
publication that highlights how metabolically-derived acylations and neighboring modifications tune BET
bromodomain binding to histones. To continue to address this broad metabolic question, we are using
biophysical, structural biology, and proteomic techniques to investigate BET bromodomain acylation and
protein selectivity in linking acyl-CoA metabolism with transcription (Focus 2). To aid our mechanistic inquiries,
we are removing a critical barrier in the study of BET bromodomain biology: the lack of inhibitors and chemical
probes that selectively target individual BET proteins. Currently, all existing BET inhibitors target Brd2, Brd3,
Brd4, and Brdt with equal nanomolar potency. This lack of selectivity may be responsible for the side effects of
memory loss and lymphoid toxicity recently associated with existing pan-BET inhibitors. We are overcoming
these barriers with a novel fragment-based ligand discovery and chemical biology strategy to discover
selective Brd4 inhibitors by covalently targeting a unique cysteine within Brd4 (Focus 3). These chemical tools
will be necessary to distinguish the differential activities of BET proteins in cell and rodent models of disease
and may also be useful in developing therapeutics targeting the Brd4 axis in cancer and diabetes.

Public health relevance
PROJECT NARRATIVE While the sequence of DNA defines what proteins are possible, which of these many DNA sequences are made into proteins is determined by “epigenetic” modifications that occur on top of (“epi”) the DNA sequence (“genetics”). The precise and combinatorial location of these modifications on the DNA sequences is controlled by proteins that “write,” “read,” and “erase” epigenetic modifications. Our research focuses on a class of proteins that “read” epigenetic modifications, which are implicated in a wide range of human diseases including cancer and diabetes, with the long-term goal of developing novel ways to target these proteins with small molecule drugs and chemical probes.